Biostatistics and Data Management Resource Core

ABSTRACT The Biostatistics and Data Management (BDM) Core will play a pivotal role in the International Uganda Russia Boston Alcohol Network for Alcohol Research Collaboration on HIV/AIDS (URBAN ARCH) Center as a full collaborator in study design, conduct, data management and statistical analyses. The overarching goal of the BDM Core is to facilitate the long-term conduct of rigorous, reproducible and innovative alcohol/HIV research. Over the next five years, the BDM Core will collaborate closely with International URBAN ARCH Center investigators by providing statistical expertise and effective data management to two research projects focused on understanding the role of alcohol use on TB acquisition, active disease, and lung disease after TB treatment among persons living with HIV (PLWH) in order to accelerate the future development of interventions that can reduce alcohol’s impact on TB-related morbidity and mortality among PLWH. The BDM Core will provide statistical and data management leadership in all phases of research to ensure high standards for data quality and statistical analyses. The BDM Core brings together an experienced team of investigators uniquely qualified to support the International URBAN ARCH Center based on their extensive knowledge of underlying scientific and clinical issues relevant to alcohol, HIV, and TB, and their long history of productive collaboration with URBAN ARCH investigators. Having this dedicated BDM Core will enhance the synergy and productivity of investigators, promote the validity and generalizability of the scientific findings, promote data sharing, and ultimately elevate the understanding of the impact of alcohol on the spectrum of TB infection among PLWH.